Partial and Controlled Depletion of SR Calcium by RyR Agonists Prevents Calcium-dependent Arrhythmias

ABSTRACT
Sympathetic stimulation of ventricular myocytes activates PKA, which phosphorylates L-type Ca2+
channels and phospholamban, among other substrates, to increase Ca2+ entry and SR Ca2+ uptake. This β-
adrenergic-induced increase of intracellular Ca2+ (Ca2+ overload) is a natural and efficient mechanism to
increase cardiac performance, inasmuch as the magnitude and force of cardiac contractions greatly depend on
the amount of Ca2+ supplied to the myofilaments. However, Ca2+ overload also increases arrhythmia vulnerability
because it brings ryanodine receptors (RyR2) closer to threshold for spontaneous Ca2+ release (SCR). SCR
during diastole activates the Na+/Ca2+ exchanger of the sarcolemma and generates a depolarizing inward current
(delayed after-depolarization or DAD) that may trigger extemporaneous actions potentials. Ca2+ overload and its
subsequent SCRs are indeed the primary events that evolve in malignant cardiac arrhythmias, as observed in
Catecholaminergic Polymorphic Ventricular Tachycardia (CPVT) and quite possibly in some forms of atrial
fibrillation, long QT, and heart failure. To prevent these Ca2+-dependent arrhythmias, an emergent group of RyR2
blockers aim to stop SCR, despite the fact that the key process that spawns SCR, namely, Ca2+ overload, may
not be affected or in some cases may be even exacerbated by the RyR2 blockers. We have found that
imperacalcin, a high-affinity, membrane-permeable selective agonist of RyRs, paradoxically decreases
arrhythmia burden and prevents Ca2+-dependent arrhythmias in animal models of CPVT. We hypothesize that
this unexpected and remarkable anti-arrhythmic effect of imperacalcin is due to a partial and controlled
depletion of SR Ca2+ load, which decreases the propensity of SCR events and thus dissipates the main
arrhythmogenic substrate in CPVT. Our research program will systematically and rigorously test this
hypothesis at the molecular, cellular, whole heart and intact animal levels using established (mouse) and novel
(rabbit) models of CPVT. The first specific aim will determine the defining structural and functional characteristics
that confer to imperacalcin and other members of the calcin family their capacity to permeate membranes and
their anti-arrhythmic properties. In the second aim, we will use native and modified calcins on intact
cardiomyocytes, Langendorff-perfused working hearts and intact animals for a rationalized design of a novel
group of RyR2 ligands capable of preventing Ca2+-triggered arrhythmias. These studies use animal models of
CPVT to develop a novel paradigm for the treatment of Ca2+ overload-generated cardiac arrhythmias; results
may be applied to other cardiomyopathies where controlled unloading of SR Ca2+ may be desirable.

Public health relevance
NARRATIVE Hyperactivity of the cardiac ryanodine receptor/Ca2+ release channel of the sarcoplasmic reticulum (RyR2) may lead to ventricular fibrillation and other lethal cardiac arrhythmias, such as occurs in the arrhythmogenic syndrome catecholaminergic polymorphyc ventricular tachycardia (CPVT), a congenital disease affecting children and young adults with an apparently normal heart. β-blockers are the standard therapy for CPVT, but it often results in incomplete protection. We discovered that selected scorpion venoms contain calcins, a family of peptide ligands of RyR2 that are able to penetrate cellular membranes and mitigate Ca2+-dependent arrhythmias due to RyR2 hyperactivity. In this study, we will develop a rationalized and novel paradigm for the treatment of CPVT based on calcins. These results may be applied to other cardiomyopathies where controlled unloading of intracellular Ca2+ may be desirable.